Enhancing the Capacity and Capability of Washington State Human and Animal Food Testing Laboratory in Support of an Integrated Food Safety System

RFA-FD-25-007 Laboratory Flexible Funding Model (LFFM)
Overall Component
Project Summary
The Washington State Department of Agriculture (WSDA) Food Safety and Consumer Services
(FS&CS) Laboratories Program is the State’s Primary Regulatory Human and Animal Food Safety
Laboratory. The laboratory and the state regulatory program are willing to follow the LFFM Sample
Guide for planning, collecting, analyzing, reporting, and follow up on LFFM samples. The laboratory is
willing to accept and analyze samples collected by FDA or other states in the event of an emergency
requiring surge capacity coordinated by FDA/FERN when the laboratory has the capability to perform
requested analyses. The laboratory has worked very closely with FDA and other federal partners in
past decades on several cooperative agreements, for instance, FDA FERN MCAP, ISO, MFRPS,
AFRPS, BSE, RRT, Produce Safety, LFFM, and USDA MDP. As an ISO 17025 accredited laboratory,
we’ve had a quality management system in place since 2011 with dedicated quality assurance staff and
procedures in place to ensure good laboratory practices. Currently, there are 16 methods under the ISO
scope. We have state-of-the-art adequate laboratory facilities to assure the proper environment for
advanced instrumentation in addition to secure sample custody and laboratory space.
The FS&CS Laboratories Program is willing and able to participate in the following 5 project areas:
(1) Discipline A Microbiology Track 1: Human Food Product Testing (500+ Tier)
(2) Discipline A Microbiology Track 2: NARMS Product Testing
(3) Discipline A Microbiology Track 4: Whole Genome Sequencing – Maintenance
(4) Discipline A Microbiology Track 7: Method Development/Validation
(5) Discipline A Microbiology Track 8: Capability/Capacity Development
The laboratory Program is located in a strategic geographic area of the United States. Washington
State is home to several major international shipping ports, through which nearly $18.5 billion in food
and agricultural products were exported in 2023. The Port of Seattle, the state’s largest city and port, is
the gateway port for all Asian and Canadian trade.
The FS&CS Laboratory is eager to be one of the Laboratory Flexible Funding Model funded
laboratories. The laboratory is committed to working with the state regulatory programs (e.g. Food
Safety Program) in taking innovative steps toward a fully integrated human and animal food safety
system. We also continue to be very appreciative of our federal grantor’s support in this endeavor and
look forward to our collaborative work in the future.
Washington State Department of Agriculture, Food Safety and Consumer Services Laboratory

Public health relevance
RFA-FD-25-007 Laboratory Flexible Funding Model (LFFM) Overall Component Project Narrative The Washington State Department of Agriculture (WSDA) Food Safety & Consumer Services (FS&CS) Laboratory Program has a history of demonstrated success as an awarded CAP member for FDA LFFM, FERN, ISO, MFRPS, AFRPS, BSE, Produce Safety, and USDA-MDP, beginning in 2000 to the present. As a CAP member, the laboratory actively participates in all activities associated with the Cooperative Agreements: sample collection, testing, proficiency testing, training seminars, conferences, face-to-face annual meetings, IT integration and method validation assignments. As an ISO17025:2017 accredited laboratory, we’ve had a quality management system in place since 2011 with a dedicated quality assurance staff and procedures in place to ensure good laboratory practices. We have laboratory facilities to assure the proper environment for advanced instrumentation in addition to secure sample custody and laboratory space. As a current FDA LFFM, MFRPS, AFRPS and RRT cooperative agreement-funded laboratory, the laboratory is applying for five years of funding through the FDA Laboratory Flexible Funding Model (LFFM) Cooperative Agreement Program’s Discipline A Microbiology Track 1, 2, 4, 7 and 8 in order to enhance the capacity and capabilities of the laboratory in support of an integrated food safety system in Washington State. The laboratory will participate in: 1. The use of various standardized cultural, biochemical and molecular analytical methods for the detection and identification of foodborne pathogens in human food product and NARMS products (Discipline A Microbiology Track 1 and 2). The laboratory will participate in human and NARMS food sample analysis for surveillance assignments, food emergency outbreak testing, and ensure large-scale food emergency event surge capacity by using various standardized cultural and biochemical analytical methods for the detection and identification of pathogens. The laboratory has trained staff and equipment to perform testing of pathogens as well as serological analysis for Listeria monocytogenes (Poly O, Type 1 and Type 4), Escherichia coli O157:H7 (O157 and H7), and E. coli STEC Big Six (all six O types). In addition, for decades, the laboratory program has utilized annual sampling agreements with our state regulatory programs. Our laboratory’s self-sample collection history dates back to 2001 as a member of the USDA AMS Microbiological Data Program (MDP) and for regulatory purposes. Training provided by USDA included aseptic sampling technique, preserving sample integrity during transit, and maintaining a complete chain of custody documentation. Our sampling experience has only grown stronger as an FDA FERN MCAP and LFFM participant. For instance, we collected over 3,600 samples in the last 2 years for testing by our FERN lab between 2018- 2020. 2. Sequence using Whole Genome Sequencing for food-borne pathogens at Maintenance level. The laboratory has trained staff and equipment to sequence and will upload data into the NCBI portal (Discipline A Track 4). 3. The Validation of a qPCR screening method for STEC in Foods (Discipline A Track 7). We have decades of history validating methods under the USDA MDP, FERN MCAP, private test manufacturers, as well as our own “Fit for Purpose” methods. 4. Gaining capacity for analytical testing (Discipline A Track 8). The laboratory needs to gain capacity by request of our food safety partners and to be a supportive member of the integrated national laboratory system. The laboratory has explored different sources to gain capacity and capability. For instance, the laboratory recently acquired a Bruker MALDI-TOF BioTyper lab instrument for rapid food-borne pathogen identification by using non-FDA funding. Additional FDA-LFFM funding support could help the program to solidify this analytical capacity. Washington State Department of Agriculture, Food Safety and Consumer Services Laboratory